Associative Processes in Episodic Memory

DESCRIPTION (provided by applicant): The proposed research seeks to illuminate the mechanisms underlying human episodic memory through both computational modeling and experimental studies. The hallmark of episodic memory is the ability to link the information that we experience with its temporal, spatial, and situational context. The ability to do so places us within our memories, making them truly autobiographical. Failures of episodic memory are a hallmark of normal aging and neurodegenerative disease. The present application seeks to further develop and test Howard &Kahana's (2002) temporal context model of episodic memory (TCM). TCM is a computational model of how temporal context is represented in memory, how it evolves through experience, and how it mediates the formation of associations and the effect of recency on memory retrieval. The current version of TCM has already generated important new insights into the basis of human associative memory. The present work seeks to advance our understanding of episodic memory by further developing and testing TCM in important new domains. Aim 1 introduces a sophisticated and neurally-plausible retrieval process into TCM. This retrieval mechanism, based on a set of accumulators with lateral inhibition, will enable TCM to address data on the timing of successive recalls. Preliminary work shows that this mechanism may also enable TCM to capture dissociations between immediate recency and long-term recency. Aim 2 incorporates a large-scale semantic memory into TCM by recasting TCM in a neural-network model with attractor dynamics. This neuro-semantic version of TCM will be applied to new data on the interaction of semantic and temporal/episodic factors in memory encoding and retrieval. Aims 3 and 4 are primarily experimental. They seek to test TCM using manipulations of task context and spatial context. Aim 5 extend TCM to address the important question of incorrect recall, or false memory. People sometimes recall things that did not happen, and TCM predicts when and why this might occur. In this aim we will test the predictions of TCM regarding both correct and incorrect recall, and use data on subjects incorrect recalls to further constrain the development of memory theory. Addressing these basic scientific questions about episodic memory will provide us with important insights into the mechanisms of memory decline both in normal aging and in neurological disease.